BDCRC - Career Enhancement Core

CAREER ENHANCEMENT CORE – PROJECT SUMMARY/ABSTRACT
The neuronal ceroid lipofuscinoses (NCLs, Batten disease) are collectively the most prevalent childhood
neurodegenerative diseases. Despite a growing understanding of the molecular and cellular pathophysiology,
too few clinician investigators are conducting NCL translational research. This hinders development of the next
wave of diagnostic and therapeutic approaches for these fatal disorders. The Batten Disease Clinical Research
Consortium (BDCRC) Career Enhancement Core aims to prepare the next generation of clinician investigators
to lead multidisciplinary, translational research in the NCLs. Specifically, we aim to (1) train diverse post-graduate
clinician investigators with interests across the translational science continuum, through a structured one-year
fellowship program in NCL research, and (2) expose diverse clinical professionals and rare-disease community
audiences to multi-modal, short-term research training opportunities focused on state-of-the-art diagnostics,
management, and research advances in the NCLs. In Aim 1, the most promising, diverse early-career clinician
investigators will be recruited and selected from fields critical to innovative translational research in NCLs and
related disorders. Funding will support career development activities and a research project for one fellow each
year. Each fellow will be paired with a BDCRC mentor to complement the existing mentoring team at their home
institution. In Aim 2, three NCL-focused educational initiatives will be launched for audiences ranging from
doctoral students to faculty: (a) clinical research immersion sprints for up to four weeks of intensive clinical
research training experience at an established BDCRC site, (b) translational research journal club to provide an
open forum for critical review of recently published manuscripts, and (c) webinars covering key challenges and
potential solutions in rare neurodegenerative disorders research, focusing on the NCLs and small-sample data
analysis. These efforts leverage resources and expertise from across BDCRC sites, existing relationships with
patient advocacy organizations, and the recent collaborative framework established by the Centers of Excellence
Program of the Batten Disease Support, Research, & Advocacy Foundation. The Career Enhancement Core's
commitment to diversity, equity, and inclusion is reflected in its approach to seek applications from individuals of
underrepresented racial/ethnic groups, individuals with disabilities, and individuals from disadvantaged
backgrounds. The Core will also prioritize gender equity as well as diversity of clinical disciplines and institutions
during the selection of trainees and speakers. The efforts of the BDCRC Career Enhancement Core align with
the Rare Disease Clinical Research Network's goal to establish and maintain an environment that fosters
collaborative, patient-oriented, multi-site, multi-disciplinary research collaborations and career enhancement.
The proposed work is directly in line with the commitment by the National Institute of Neurological Disorders and
Stroke to develop researchers that are diverse, are trained in the rigorous conduct of science, and possess the
skills needed to thrive in an ever-changing research landscape.